The effects of respiratory-based treatment for muscle tension dysphonia: a randomized controlled trial

Project Summary/Abstract
Primary muscle tension dysphonia is a voice disorder that involves excessive and poorly coordinated muscle
activity affecting multiple subsystems that are involved in speech production, in the absence of structural or
neurologic abnormalities of the larynx. Primary muscle tension dysphonia (MTD) is one of the most common
forms of voice disorders, accounting for at least 40% of patients seen in voice clinics. Perceptually the voice
sounds hoarse and strained, with reduced loudness and pitch range, and people with MTD find speaking very
effortful and fatiguing. The physiological abnormalities that characterize MTD are considered multifactorial, and
include over-activity of muscles in and around the larynx, laryngeal constriction patterns, and abnormal speech
breathing patterns. However, standard treatment approaches for MTD primarily address laryngeal function,
including repositioning of laryngeal structures, reducing activity in the intrinsic and extrinsic laryngeal muscles,
and altering vibratory patterns. Although voice improvement may follow these treatments, many people with MTD
show recurrence of voice problems after only a few months, and some do not improve with treatment. These
findings highlight the need for alternative treatments that address the respiratory contributions to MTD, with
training targets that are based on the specific physiologic deficits of the respiratory subsystem, which directly
affect the phonatory system. The goal of this project is to determine the effects of respiratory-based treatment
focused on altering lung volume levels in people with MTD, and compare those effects to a control condition. A
randomized group design will be implemented to determine the respiratory and acoustic effects of each condition,
and the association between voice change and laryngeal biomechanics. We will determine the effects of each
condition immediately after and then 3 and 6 months after treatment completion to assess short- and long-term
treatment effects. We propose that altering the levels at which speech breaths are initiated and ended (lung
volume initiation and termination) while speaking will have a positive effect on related laryngeal behavior and
voice. The proposed project has the potential to substantially advance the evidence-based treatment options for
MTD, providing a vital step toward reducing the debilitating effects of this disorder.

Public health relevance
The narrative is not required for Diversity Supplement applications.